A dual proteolytic axis regulates osteoclast-mediated bone coupling activity

Abstract
Skeletal homeostasis reflects a balanced state of bone remodeling, requiring a combination of osteoclast-
dependent bone resorption and osteoblast-mediated bone formation. In turn, pathologic bone remodeling
precipitates a variety of bone-destructive disease states, ranging from osteoporosis to rheumatoid arthritis. In
addition to the traditional role of osteoclasts as "bone eaters", these cells also participate in the maintenance of
bone homeostasis via the release of signaling molecules that establish crosstalk with osteoblast-lineage cells.
Despite advances in the field, however, the molecular mechanisms that allow osteoclasts to both degrade and
induce new bone formation in a timely fashion remain to be defined. In new studies, we have found that cathepsin
K (Ctsk)-null osteoclasts dramatically upregulate expression of the membrane-anchored matrix
metalloproteinase, Mmp14/MT1-MMP, raising the possibility that, working together, the two proteinases play a
previously unrecognized role in regulating osteoclast function. As such, we generated myeloid-specific Csf1r-
Cre/Mmp14f/f/Ctskf/f mice where we find that the double knockout (DKO) mice unexpectedly display striking
increases in bone mass and osteogenic coupling activity relative to myeloid-specific cathepsin K-null (CtskΔM/ΔM)
or Mmp14-null (Mmp14ΔM/ΔM) mice. Further, the up-regulated bone formation parameters observed in these mice
occur while leaving bone resorptive activity comparable to that found in CtskΔM/ΔM mice. In an effort to define the
mechanisms underlying a combined requirement for Mmp14 and Ctsk in osteoclast-mediated bone coupling
activity, the transcriptome of DKO osteoclasts reveals unexpected alterations in TGFβ receptor signaling in
tandem with the decreased expression of the tetraspanin family member, Tspan4. These findings led us to posit
a new model wherein Mmp14 and Ctsk co-regulate the TGFβ/Smad-dependent control of Tspan4 whose
expression directs the formation of osteoclast migrasomes, a new type of organelle/extracellular vesicle
deposited by migrating cells. Further, we provide supporting evidence that wild-type osteoclast-derived
migrasomes negatively regulate skeletal stem/progenitor cell recruitment and osteoblastogenesis, thereby
preventing premature or unrestrained bone formation. In turn, migrasome-deficient DKO osteoclasts create
conditions permissive for excessive osteogenesis and bone formation. Given these preliminary findings, we
propose to i) characterize the cooperative role played by a new Mmp14/Ctsk couplet in controlling osteoclast-
mediated osteogenic bone coupling functions in vitro and in vivo, utilizing both myeloid- and osteoclast-specific
conditional knockout mice; ii) define a novel Mmp14/Ctsk-TGF-β/Smad-Tspan4 axis that regulates osteoclast
migrasome formation and bone coupling activity in vitro and in vivo, and iii) identify the osteoclast-derived
migrasome component(s) that control osteoblastogenic recruitment and commitment of skeletal stem/progenitor
cells. The proteolytic/bone coupling synergy outlined herein should provide new insights into bone remodeling
while advancing the search for improved therapeutic interventions designed to prevent pathologic bone loss.

Public health relevance
Narrative While the phenomenon of bone coupling, i.e., the complex spatial and temporal crosstalk that occurs between osteoclast-mediated bone resorption and osteoblast-dependent bone formation, is well appreciated, the molecular mechanisms that transduce signaling between osteoclasts and osteoblasts remain poorly defined. Herein, we describe a body of preliminary evidence wherein two osteoclast-derived proteolytic enzymes, the cysteine proteinase, cathepsin K (Ctsk), and the membrane-anchored matrix metalloproteinase, Mmp14/MT1- MMP, control the TGFβ/Smad/Tspan4-dependent deposition of migrasomes, a new form of extracellular vesicle that acts as a key "braking" mechanism to negatively regulate bone formation with the result that the osteoclast- specific knockout of both enzymes decreases migrasome formation, thereby triggering massive formation of new bone in vivo. The results of this study should not only shed new mechanistic light on a novel form of proteolytic crosstalk that controls bone coupling, but also identify new targets for therapeutic intervention in osteolytic disease states.